CTSA K12 Program at Stanford

PROJECT SUMMARY/ABSTRACT
Training the next generation of translational scholars who can innovate, think creatively, and apply
rigorous and responsible research principles to major problems is society's best chance to recoup its
enormous investment in biomedical research. The Stanford CTSA's proposed Mentored Research Career
Development Program (K12) sits at the center of a dynamic Stanford and Silicon Valley ecosystem of
biomedical research at all stages, from basic discovery to practical implementation. Our KL2 program has a
15-year history of successfully training Scholars to become exceptional scientists, leaders and mentors. Our
Scholars have over 2,749 publications (average 58 each) cited over 45,000 times since graduation, and all
who have graduated since 2021 in the last two cycles have received subsequent independent research
funding. That success has rested on a philosophy of practical, individualized training tailored to the Scholars
and focused on the established characteristics of successful translational scientists. We will provide tailored
mentoring and career development for four to five instructors and junior faculty from diverse backgrounds each
year. Our alliance with the VA early career and Center for Digital Health training programs brings new
colleagues into our scholarly community.
Thematic emphases include community engagement, interdisciplinary teams and leveraging
developments in informatics to accelerate translational research and rigor and reproducibility of clinical
research to ensure that translated products will truly benefit patients. The science of translation brings that
rigor to the study of moving research across the translational spectrum and is embedded throughout our
program. We have strong recruitment plan to enhance diversity, and have substantially expanded Scholar
training in that area with an innovative advanced program.
We structure our program around four specific aims: mentorship, education and professional
development, evaluation, and impact. We have assembled a world-class faculty who are committed to training
and mentoring our Scholars who together have a research program funded in excess of $350 million. The
MPIs are both award-winning mentors with strong experience in leading large research projects and synergistic
strengths. We have also assembled an outstanding teams of mentors specific to community engagement and
analytic methods, as well as a strong emphasis on peer mentoring. The education and professional
development aim covers not just the domains of translational research and the science of translation but
lectures and experiences designed to imbue Scholars with the practical and leadership skills they will need to
succeed. Our diverse External Advisory Board of nationally renowned educators and scientists will, together
with the Community Advisory Board, give the program strategic guidance. A robust evaluation and a long-term
outcomes tracking plan ensures that we will continuously improve this program and maximize impact.

Public health relevance
PROJECT NARRATIVE Stanford CTSA's Mentored Research Career Development Program (K12) will train the next generation of translational Scholars in biomedical research. The program emphasizes practical, individualized training tailored to the Scholars and focuses on community engagement, informatics, and rigor and reproducibility, and the new science of translation to ensure translated products truly benefit patients from all walks of life. Our accomplished faculty are committed to mentoring Scholars across disciplines and translational stages and building on a 15-year history of diverse scholars who have gone on to independent research funding and leadership roles.